Putting CDSMP to Work: Implementation of the Live Healthy, Work Healthy Program

DESCRIPTION (provided by applicant): This project proposes to test adaptations of the Chronic Disease Self-Management Program (CDSMP) designed to increase the likelihood of widespread use in workplace settings. CDSMP, which has been proven efficacious in community trials, is a six-week program that is designed to help individuals better manage their chronic disease and its many complications. Although there is considerable interest among worksite health promotion practitioners for a chronic disease program, CDSMP has not been adapted and tested in workplace settings. In this study, we will determine a) if the CDSMP program tailored to worksites can be efficacious, b) the comparative effectiveness of the worksite tailored CDSMP when compared to the original CDSMP and c) the cost-effectiveness (average and incremental) and return on investment of the two interventions. The participating sites are seven organizations from a rural county in Southwest Georgia. Our partner for the project is the local YMCA. YMCA staff will be trained to implement the program which will foster sustainability. Participants will be randomly assigned to 1) workplace-tailored CDSMP, 2) 'usual care' CDSMP, and 3) control group. Data will collect at baseline, 6-month follow-up and 12-months follow-up. The control group will be a delayed intervention group that will be randomly assigned to an intervention group after taking the 6 month survey. The primary outcome measures include blood pressure, cholesterol, blood glucose, BMI, diet, physical activity and tobacco use and the secondary measures including patient-provider communication, quality of life, medical adherence, and work performance and productivity. An average cost-effectiveness analysis will compare interventions to control and an incremental cost-effectiveness analysis will be conducted comparing each intervention to one another. The hypotheses will be tested using a growth modeling approach examining changes over time. This will enable us to maximize the dissemination and implementation of CDSMP across worksite populations by using approaches which are realistic for most work organizations.

Public health relevance
PUBLIC HEALTH RELEVANCE: The existence of high quality research findings does not in itself assure good practice. In order to effectively disseminate research to practice, we must understand which interventions found efficacious in clinical or community settings can be translated into a worksite setting. These interventions must be adapted to the context and culture of the setting and target population to maximize the effects of the intervention. This project translates an efficacious program (Chronic Disease Self-Management Program) to a broader public health population, testing adaptations that will foster widespread use in worksite settings. This will enable public health professionals to maximize the impact of an efficacious program, reaching a much larger population than possible in clinical settings.